MS-ISPCTN (Cycle 3)

The University of Mississippi Medical Center (UMMC), Children’s of Mississippi, and the UMMC Department of Pediatrics are seeking to continue to be a site for the ECHO IDeA States Pediatric Clinical Trials Network-3 (ISPCTN-3). Our site, the Mississippi ECHO ISPCTN (MS-ISPCTN) has made considerable progress with implementation of the initial ISPCTN funding in 2016, greatly expanding our local site’s infrastructure and completing 7 pediatric trials We stood up and are conducting an additional study (RAMP) during this budget year. Our ISPCTN site has increased readiness for pediatric trials through increasing pediatric research infrastructure during the first two funding cycles. The capacity of our site has grown considerably through ISPCTN provided trainings, collaborations with other sites, and collaboration with the Mississippi Center for Clinical and Translational Research (MCCTR). Our team has gained experience in trial recruitment and will continue to build capacity for recruitment in varied communities and engagement of local leaders during ISPCTN-3. Site investigators at UMMC have made important contributions to the ISPCTN program, leading working groups and developing a pediatric trial. Scholarly work products have grown through collaborations established within the ISPCTN. With MS-ISPCTN-3, our site will continue to be fully engaged with ECHO ISPCTN trials. With ISPCTN-3 we will develop 3 clinical trial concepts that address ECHO disease priorities for consideration by the Network. In addition, our junior faculty will develop a research protocol that informs a multi-center trial. We are committed to participate in a minimum of 5 network clinical trials during cycle 3. Our MS-ISPCTN site is poised to become a major pediatric research center in the underresourced communities in Mississippi. With continued support, our site will contribute new data from trials that extend into all demographics of Mississippi, thus increasing the generalizability from pediatric research.

Public health relevance
Located in a largely high need, non-metropolitan region, the Mississippi site for the ECHO IDeA States Pediatric Clinical Trials Network-3 (MS-ISPCTN-3) seeks to develop, conduct, and disseminate results from state-of-the-art clinical trials that include participation of children living in Mississippi communities while building local research capacity and infrastructure. To maximize the impact, transferability, rigor, and feasibility of ISPCTN clinical trials, MS-ISPCTN-3 will intentionally engage local thought experts, non-profit organizations, and professional societies in local network activities. To ensure a sustained impact, MS-ISPCTN-3 commits to train future leaders for research focusing on children living in under-resourced areas.